1Florida Alzheimer's Disease Research Center Data Management and Statistical (DMS) Core

Summary/Abstract: Data Management and Statistical Core, 1Florida ADRC
The Data Management and Statistical Core of the 1Florida ADRC functions as key connective fiber that links
the various cores of the center, provides the principal point of contact with internal and external investigators and
trainees, and is the primary conduit to the National Alzheimer’s Coordinating Center (NACC), both for the delivery
of data, and for the acquisition of data sets for local investigators. The Core also exists to ensure rigor and
reproducibility at every step of data handling, from entry and coding, through analysis and dissemination.
Consistent with the central themes of the 1Florida ADRC, the Core (a) consolidates, de-identifies and provides
biomarker data to investigators, (b) puts particular emphasis on data analysis methods for longitudinal analysis,
particularly in supporting and educating early career investigators in their use, (c) supports biomedical informatics
and e-health investigators in accessing and using large data repositories (e.g., the One Florida Data Trust) for
development of novel hypotheses regarding dementias. The core also provides leadership in the collaborative
development of open source applications for the coding and transmission of data. Aims of the Core include:
(1) providing high quality data management processes and systems to data that has been validated,
integrated/merged (across Center operations), is secure, well documented, and shared with other investigators
locally and nationally;
(2) providing up-to-date data analysis consultation in a) study design, b) selection of study measures, c) data
analysis, d) interpretation of findings, and e) presentation, before, during and after data collection and analysis.
The core also ensures rigor and reproducibility of 1Florida ADRC research by supporting (a) pre-registration of
manuscripts, (b) use of reproducible and open source code for data analyses, (c) use of preprint publication of
manuscripts for wide dissemination and “open peer review”.
(3) supporting the larger community of ADRC investigators nationally, and those affiliated with the 1Florida
ADRC, with open source data management tools and applications; as well as with
42 online training modules (with practice data sets and code), via the Research Education Component, in
methods ranging from simple descriptive to advance growth and survival models.